Core A: Administrative

PROJECT SUMMARY – CORE A: ADMINISTRATIVE
The Administrative Core will coordinate the scientific, administrative, and financial functions of our
multi-project, multi-institution Center. It will ensure that the Center, and the work therein, performs as a
cohesive and coordinated entity to maximize the impact of the associated investigators. It will build on the
long-running, highly productive collaborations between the Project and Core leads and leverage the
experienced administrative infrastructure at UW’s Institute for Protein Design, led by Dr. Lynda Stuart, to meet
the needs of the Center. The Administrative Core is a central unit overseeing and supporting all Center
components (five Projects, five Cores) and will ensure that the scientific team remains focused on the main
goal of the Center: to develop generalizable strategies for paramyxovirus and bunyavirus vaccine design. The
Core leadership will also ensure effective communication between other ReVAMPP Centers and the NIH
programmatic staff. The goals of the Core will be: 1) to provide organizational governance and oversight to the
Center, 2) to ensure effective and efficient communication and collaboration between the Center members, and
3) to maximize the engagement between our Center and the broader scientific community, including the other
ReVAMPP Centers.